Interpretation Bias Training in Depressed Adolescents: Effects and Mechanisms

DESCRIPTION (provided by applicant): Adolescence is a period of high risk for the onset of Major Depressive Disorder (MDD); indeed, adolescent onset of MDD is associated with longer and more severe depressive episodes that are often refractory to treatment. Thus, it is imperative that we identify factors involved in early-onset MDD and develop more effective approaches to early intervention. In attempting to elucidate factors that contribute to the onset and maintenance of MDD, investigators have focused on negatively biased processing of information. The most consistent cognitive bias in depression involves more negative and less positive interpretations of emotionally ambiguous information. Importantly, investigators have shown not only that these biases in interpretation can be modified, but further, that Interpretatio Bias Training (IBT) improves emotion regulation and reduces depressive symptoms. Despite these findings, however, we know little about the mechanisms that underlie these positive effects of IBT. In an effort to gain a more comprehensive understanding of biased cognitive functioning in MDD, researchers have begun to examine neural aspects of biases in this disorder. In this context, investigators have documented abnormalities in function, connectivity, and/or structure in depressed adults in subgenual and dorsal anterior cingulate (ACC), dorsal prefrontal cortex (PFC), and amygdala, all components of emotion regulatory networks. To date, there is little research examining the neural foundations of cognitive biases in depressed children and adolescents or the effects of modifying these biases in depressed youth. The overarching goals of the proposed project are (1) to assess the cognitive, neural, and clinical effects of training designed to reduce negative interpretation biases in depressed adolescents; and (2) to examine neural and cognitive changes that mediate the positive clinical effects of IBT. Results of this project will increase our understanding of neural processes that underlie interpretation biases in depressed adolescents and contribute to the development of more effective interventions for MDD in adolescence.

Public health relevance
PUBLIC HEALTH RELEVANCE: Major Depressive Disorder (MDD) is among the most prevalent of all psychiatric disorders; almost 20% of the U.S. population will experience a clinically significant episode of depression during their lifetime. Adolescence is a period of high risk for the onset of MDD; indeed, 25% of adolescents will experience an episode of MDD by the end of their teen years. The proposed project is designed to assess the cognitive, neural, and clinical effects of training designed to reduce negative interpretation biases in depressed adolescents and to examine neural and cognitive changes that mediate the positive clinical effects of this training. Results of this project will increase our understanding of neural processes that underlie interpretation biases in depressed adolescents and will aid in the development of more effective interventions for MDD in adolescence. __SpecificAimsTextDelimiter__ Aims Major Depressive Disorder (MDD) is among the most prevalent of all psychiatric disorders. Almost 20% of the American population, or more than 30 million individuals, will experience an episode of MDD during their lifetime [1]. Depression is also a highly recurrent disorder: 75% of depressed individuals experience several depressive episodes, often relapsing within two years of recovery [1,2]. Thus, it is not surprising that the World Health Organization (2004) projects that MDD will be the single most burdensome disease in the world in this century. Importantly, half of adults with MDD report experiencing an onset during adolescence [1,3]. In fact, it is now apparent that adolescence is a critical developmental period of vulnerability for depression: one-quarter of all adolescents will experience an episode of MDD by the end of their teen-age years [4], a figure that appears to be increasing over time [1,5]. Moreover, adolescent onset of MDD is associated with longer and more severe depressive episodes that are often refractory to treatment [6]. Clearly, it is imperative that we identify factors involved in early-onset MDD and develop more effective approaches to early intervention. In attempting to delineate factors that contribute to the onset and maintenance of MDD, investigators have made significant progress elucidating the nature of negatively biased processing of information in depressed adults. In a recent meta-analysis, Hallion and Ruscio [7] concluded that the most consistent cognitive bias in depression involves more negative and less positive interpretations of emotionally ambiguous information. Importantly, investigators have shown not only that these biases in interpretation can be modified, but further, that Interpretation Bias Training (IBT) improves emotion regulation and reduces depressive symptoms [8]. In an effort to gain a more comprehensive understanding of biased cognitive functioning in MDD, investigators have begun to examine neural aspects of biases in this disorder. In this context, researchers have documented abnormalities in function, connectivity, and structure in depressed adults in subgenual and dorsal anterior cingulate (ACC), dorsal prefrontal cortex (PFC), and amygdala, all components of emotion regulatory networks [8-12]. Despite this progress in our understanding of MDD in adults, however, we know little about the neural foundations of cognitive biases in depressed children and adolescents, and whether these biases can be modified to reduce depressive symptoms in youth. In this application we propose to assess the cognitive, neural, and clinical effects of training designed to reduce negative interpretation biases in depressed adolescents, and to examine neural and cognitive changes that mediate the clinical effects of IBT. Results of this project will contribute to the development of more effective interventions for MDD in adolescents. Aim 1: Assess cognitive, neural, and clinical effects of reducing negative interpretation biases in depressed adolescents. This is the first study to examine the effects of IBT in depressed adolescents. Cognitive, neural, and clinical functioning will be assessed before and after depressed adolescents participate in two weeks of real or sham IBT. Hypothesis 1a - Cognitive effects: Compared with depressed adolescents who receive sham IBT, depressed adolescents who receive real IBT will exhibit a greater reduction in negative interpretation biases from pre- to post-training (near transfer effects). Further, we hypothesize that modifying interpretation biases in depressed adolescents will have secondary effects on negative biases in attention and memory (far transfer effects) that have been found to characterize MDD. Hypothesis 1b - Neural effects: Compared to depressed adolescents who receive sham IBT, depressed adolescents who receive real IBT will exhibit a greater decrease from pre- to post-training in activations in brain regions responsive to negative stimuli and a greater increase in activations of regions reactive to positive stimuli; they will also exhibit a greater decrease in limbic activation to emotionally ambiguous stimuli. More specifically, following real IBT depressed adolescents will exhibit decreased amygdala activation to sad and emotionally ambiguous faces and increased activation in nucleus accumbens (NAcc) to happy faces. Finally, based on findings obtained with depressed adults (e.g., [10]), we predict that, compared with depressed adolescents who receive sham IBT, depressed adolescents who receive real IBT will exhibit a greater decrease in connectivity between subgenual anterior cingulate cortex and ventromedial prefrontal cortex during a resting-state scan, reflecting a reduction in self-focused depressive rumination and in self-generated negative affect. Hypothesis 1c - Clinical effects: Depressed adolescents who receive real IBT will exhibit a greater reduction in depressive symptoms from pre- to post-training than will depressed adolescents assigned to a sham IBT condition. Moreover, these effects will be maintained at a three-month follow-up assessment. Aim 2: Examine the mechanisms through which IBT produces clinical change in depressed adolescents. Hypothesis 1a: Training-related reductions in depressive symptoms both immediately following real IBT and at the three-month follow-up assessment will be mediated by reductions from pre- to post-training in negative biases in cognitive processing and in anomalous patterns of neural activation and connectivity. We will conduct exploratory analyses to examine whether symptom improvement as a result of IBT both at post- training and at the three-month follow-up assessment is predicted more strongly by changes in biases in interpretation, attention, or memory, or by changes in patterns of neural activation and connectivity.